The Regulation of Human Hydroxysteroid Sulfotransferase by Nuclear Receptor ROR

DESCRIPTION (provided by applicant): The goal of this proposal is to explore the novel role of the retinoid-related orphan receptors (RORs) in the regulation of the human hydroxysteroid sulfotransferase SULT2A1, a Phase II enzyme important for the metabolism of bile acids and many other xenobiotics and endobiotics. RORs were previously known to play a role in tissue development and circadian rhythm. Among three ROR isoforms, RORα and RORγ are expressed in the liver, but their hepatic function remains unknown. It has recently been reported that certain hepatic CYP enzymes, such as CYP7B1 and CYP2C8, can be transcriptionally regulated by RORs, suggesting a broader role of these orphan receptors in xeno- and endobiotic enzyme regulation. Our preliminary results showed that: 1) The expression of ROR? was negatively correlated to the expression of SULT2A1 in primary human hepatocytes; 2) Overexpression of ROR? inhibited the expression of endogenous SULT2A1 in HepG2 cells; 3) A ROR response element (RORE) has been identified in the SULT2A1 gene promoter that overlaps a CAR response element (CARE) on the same promoter; and 4) The positive regulation of SULT2A1 gene promoter by CAR was inhibited by the co-transfection of ROR?. Based on our preliminary data, we hypothesize that RORα and/or RORγ have a previously unrecognized role in the regulation of the human hydroxysteroid sulfotransferase SULT2A1. Specifically, we hypothesize that: 1) The expression of RORα and/or RORγ is negatively correlated to the expression of SULT2A1 in the human liver; and 2) The human SULT2A1 gene promoter is a transcriptional target of RORs. We propose two specific aims to test our hypotheses: (1) To determine whether the expression of RORα and RORγ correlates to the expression of SULT2A1 in the human liver; and (2) To determine the molecular mechanism by which RORα and RORγ regulate the expression of SULT2A1 gene. To our knowledge, this study represents the first attempt to systematically evaluate the novel function of RORα and RORγ in regulating hepatic drug metabolizing enzymes in humans. SULT2A1-mediated bile acid sulfation and detoxification play an important role in the prevention and relief of cholestasis. Results from this study may help to understand the role of RORs in the interindividual variation of SULT2A1 gene expression and the propensity to cholestasis in patients. RORs were previously known for their roles in tissue development and circadian rhythm. The current application represents an innovative and paradigm-shifting project that meets the missions of the NIH R21 Exploratory Developmental Research Grant Program. PUBLIC HEALTH RELEVANCE: This application addresses the regulation of the human hydroxysteroid sulfotransferase (SULT2A1), a Phase II drug-metabolizing enzyme, by the retinoid-related orphan receptors (RORs). RORs are previously known for their roles in tissue development and circadian rhythm, the current application represents an innovative and paradigm-shifting project that meets the missions of the NIH R21 Exploratory Developmental Research Grant Program. SULT2A1 is important for the metabolism of bile acids and relief of cholestasis. Results from this study may help to understand the role of RORs in the interindividual variation of SULT2A1 gene expression and the propensity to cholestasis in patients.

Public health relevance
Project Narrative This application addresses the regulation of the human hydroxysteroid sulfotransferase (SULT2A1), a Phase II drug-metabolizing enzyme, by the retinoid-related orphan receptors (RORs). RORs are previously known for their roles in tissue development and circadian rhythm, the current application represents an innovative and paradigm-shifting project that meets the missions of the NIH R21 Exploratory Developmental Research Grant Program. SULT2A1 is important for the metabolism of bile acids and relief of cholestasis. Results from this study may help to understand the role of RORs in the interindividual variation of SULT2A1 gene expression and the propensity to cholestasis in patients.